META TERPHENYL PHOSPHINIDENE TRANSITION METAL COMPLEXES

Our work is directed at the synthesis of new hindered phosphines and phosphaketenes based on meta-terphenyl arryl phosphines(2,6-diarylphenyl phosphines). These new species will be used in studies aimed at the synthesis and reactivity of terminal phoshinidene complexes. The meta-terphenyl aryl systems not only offer the necessary steric environment for such a task, but also have several desirable features. Unlike previous studies using the 2,4,6-tri-tert-butylphenylphoshine (Mes*PH2), the current studies use complexes that have a more accessible M=PAr core for reactivity studies - Secondly, the presence of the flanking aryl groups about the phosphorus atoms may yield complexes where pi-complexation of one of the aryl groups to chelate to the metal center and stabilize "bent" phosphinidenes in cases where normally the "linear" phosphinidene would be favored. Mass spectrometry is needed to ascertain compound purity and identity.